Lung Cancer: A Multimedia Decision Guide

DESCRIPTION (provided by applicant): HealthMark Multimedia will develop a prototype multimedia education and decision-making CDROM for lung cancer patients and their family members. The product will provide information needed after a diagnosis of lung cancer, decision aids to assist the newly diagnosed patient in working with the health care team in the treatment decision process and interactive skill demonstrations to teach and reinforce skills for physical management of the disease. The CD-ROM will be designed as "information therapy" to be prescribed by health care professionals caring for lung cancer patients. In Phase I, the information and skill needs of patients will be translated into an interactive prototype that will be tested for usability and for knowledge and self-efficacy gains. The patient CD-ROM will be reviewed by health care professionals to determine specific methods for assisting a professional in suggesting all or part of the product to a patient as information therapy. In Phase II, the full patient CD-ROM and accompanying health care professionals' guide to using the product to increase patient involvement in treatment decisions and self-care will be developed. The effectiveness of the product in increasing patient knowledge, decisional self-efficacy and self-care skills will be determined.